Complexity and evolution of splicing-regulatory networks

Complexity and evolution of splicing-regulatory networks
Project Summary
Alternative splicing (AS) generates multiple transcript isoforms from single genes and contributes critically to the
molecular, cellular and phenotypic complexity of mammals. This process is tightly regulated by RNA-binding
proteins (RBPs) which recognize specific regulatory elements in their target transcripts. A long-standing
hypothesis from the evolutionary perspective is that changes of AS regulation due to mutations in cis-regulatory
sequences provide a major driving force of speciation in mammals, including closely related species such as
human and Chimpanzee. Indeed, divergent AS events are pervasive in different mammalian species, as well as
in human populations as evident from widespread splicing quantitative trait loci (sQTLs). Despite remarkable
progress in studies of splicing-regulatory networks over the past decade, our understanding of the splicing code
remains very incomplete, leaving critical questions such as 1) which evolutionary splicing changes in different
species or in human populations have functional implications? 2) what are the underlying mutations/genetic
variations that led to the divergent splicing patterns? Building on our previous work on splicing-regulatory
networks, this research program aims to address these questions. We will develop computational methods and
experimental model systems to identify AS events under adaptive selection in specific lineages and map
mutations leading to changes in splicing-regulatory elements that underlie splicing divergence. Insights learned
from evolutionary changes that represent nature’s experiments will be leveraged to develop a more predictive
splicing code. In these studies, computational and experimental approaches including new technology
development are closely integrated by our multidisciplinary team. If successful, this study will provide
tremendous insights into the contribution of AS evolution to potential phenotypic differences among different
mammalian species, to health and disease in humans, and to fundamental understanding of RNA splicing
regulation.

Public health relevance
Project Narrative Alternative splicing (AS) is critical for expanding the complexity of genetic information encoded in the mammalian genome. Mutations affecting AS regulation provide an important source of genetic innovations during evolution, but are also implicated in an expanding list of genetic diseases ranging from neurological disorders to cancer. Discoveries from this study can be highly relevant to understand human traits and susceptibility to genetic diseases.